The Personalized Remote Radiation Tracking Portable Organ Dosimetry Devise (PRRT PODD)

Theranostics is a type of precision medicine in which targeted radiolabeled compounds are being used for both
diagnosis and treatment. Targeted therapies can increase therapeutic effectiveness while limiting side effects.
Since the publication of the NETTER1 trial results (1,2), the use of 177Lu-DOTATATE to treat neuroendocrine
tumor (NET) patients has increased significantly. The protocol for the trail was four 200 mCi administered
treatments at 8-week intervals. This protocol received FDA approval in the United States and has become the
standard of care (SOC) for most sites throughout the world. On the other hand, there is a large group of
physicians and scientists that believe 177Lu-DOTATATE treatments should be personalized for each patient.
177Lu emits electrons for therapy, but it also emits gammas that can be used for imaging. Therefore, it is possible
to quantitate dose to a person’s organs at risk (OAR) and tumors using imaging techniques, such as SPECT/CT.
Assessing OAR dosimetry after each treatment allows for personalization of 177Lu-DOTATATE therapy.
Retrospective studies have demonstrated significant lengthening of progression free survival (33 vs. 15 mos)
and overall survival (54 vs. 25 mos) when patients were able to continue treatments up to 23 Gy delivered dose
to their kidneys (4). In addition to OAR dosimetry, there is growing interest in personalizing therapies based upon
tumor biology. Thus, the goal of this work is to develop and validate a cost effective, patient friendly technology
that will enable personalization of 177Lu-DOTATATE using daily measurements of the radioactivity in the patient’s
OAR and tumors without requiring serial visits to an imaging center. The Personalized Remote Radiation
Tracking Portable Organ Dosimetry Device, PRRT PODD or PODD for short, is a patient-friendly radiation
measuring device that the patient can use in their homes. The primary OAR is the patient’s kidney; however, the
PODD will also provide data for accurate dose estimation of other OAR and physician selected tumors, thus
enabling treatment personalization based upon maximum tolerated dose to OAR, cumulative tumor dose,
therapeutic ratio (i.e., ratio of tumor dose to dose to OAR), or other dosimetry-based metrics. Our project consists
of four specific aims: 1) Design, develop, and characterize compact imaging detectors and associated software
tools for use with the PODD; 2) Use realistic, digital NET patient phantoms and simulation tools to optimize
PODD design for both OAR and tumor dosimetry; 3) In clinic patient studies to validate quantitative organ and
tumor measurement capabilities of PODD; and 4) Conduct a patient study including at home measurements
comparing OAR and tumor dosimetry estimates using PODD to serial SPECT/CT imaging. At the conclusion of
this project, we will have validated our PRRT PODD technology on a 36-patient cohort and the technology will
be ready to support clinical trials to study the benefits to patients of personalized 177Lu-DOTATATE therapies,
where personalization can be based on dose to patients’ OAR or tumors and on tumor biology.

Public health relevance
Narrative The overall goal of this work is to improve outcomes for neuroendocrine tumor (NET) patients by fashioning cost effective, patient friendly technology to enable 177Lu-DOTATATE treatment personalization based upon daily, at- home measurements of the radioactivity in their organs at risk and tumors. We are developing compact, durable, easily transportable technology that will enable treatment personalization while forgoing the need for serial visits to imaging centers over 7 plus days for each treatment administration.